Consequences of Exposure to Repetitive Head Impacts Across the Lifespan

Each year, millions of people are exposed to repetitive head impacts (RHI) from contact sports, military service,
and interpersonal violence. Although RHI typically occurs early in life, the health consequences of RHI evolve
over the lifespan and include neurobehavioral symptoms, cognitive impairment, and increased risk for
Alzheimer's disease (AD) and AD-related dementias (ADRD), including chronic traumatic encephalopathy (CTE).
In 2014, our team secured a U01 grant to establish the UNITE brain bank to investigate the long-term clinical
and neuropathological outcomes of RHI exposure. Subsequent funding as a U54 grant expanded UNITE into
the world's largest RHI and CTE brain tissue repository, totaling 1520 brains. Through UNITE, we have
pioneered research delineating the neuropathological consequences of RHI, particularly in later life, including
the development of diagnostic criteria for CTE, demonstrating the dose-dependent relationship between RHI
exposure and risk for CTE and AD/ADRD, and elucidating how RHI contributes to clinical symptoms such as
dementia through multiple pathological mechanisms. With rising numbers of young brain donors in UNITE, our
latest studies have focused on young athletes. We recently showed that RHI experienced early in life initiates
structural brain changes, perivascular hemosiderin-laden macrophages, gene expression changes,
inflammation, microvascular alterations, neuronal and white matter (WM) loss, and perivascular ptau as CTE
stage I-II in young athletes (<30 yrs) before the development of AD/ADRDs, and severe CTE. This proposal
addresses a critical knowledge gap by examining how early-life RHI-induced brain alterations progress into latent
neurodegeneration with aging, independent of further RHI exposure. The overarching goal of this proposal is to
identify the early-life RHI-induced alterations that promote late-life CTE, AD, and ADRD neurodegeneration.
Accordingly, this proposal has three aims spanning the adult lifecycle. The first aim will determine the clinical
and pathological consequences of RHI in young adults aged 18-39 years, a period close to RHI exposure. The
second aim will determine the consequences of RHI at mid-life, age 40-59 years, and the third aim will determine
the consequences of RHI in late life, age 60-79 years. At all three time periods, we will examine how these early
RHI-induced pathological, imaging, and clinical outcomes are modified by cardiovascular and metabolic disease,
socioeconomic, sex, race, and lifestyle factors, and genetic variations (APOE ε4, TMEM106b, MAPT). To
achieve these aims, we will employ cutting-edge neuropathological and imaging technologies, including multiplex
immunofluorescence with advanced digital quantitation, single nucleus RNA sequencing (snRNA seq), spatial
transcriptomics, optically cleared sections of postmortem human brain with 3D imaging (Clarity), novel AI
machine learning, and ex vivo MRI with Connectome 2 analysis to precisely quantitate the changes that occur
over the lifespan after early life RHI exposure. This proposal will spotlight biomarkers for early detection and
potential therapeutic targets to interrupt AD, ADRD, and CTE in young to mid-life.

Public health relevance
Millions of people each year are exposed to repetitive head impacts (RHI) from contact sports and military service. The health consequences of RHI evolve over the lifespan and include increased risk for Alzheimer's disease (AD) and AD-related dementias (ADRD), including chronic traumatic encephalopathy (CTE). The goal of this proposal is to identify the early-life RHI-induced alterations that promote late-life AD, ADRD, and CTE neurodegeneration.